Glycomics Laboratory for the Development of Ovarian Cancer Biomarkers

ABSTRACT
Ovarian cancer is a silent killer with few early symptoms and advanced disease often present at the time of
diagnosis. This cancer is the most lethal of all gynecologic malignancies with over 20,000 new cases
diagnosed each year. The 5 year survival rates for ovarian cancer dramatically improve when the disease is
diagnosed at an earlier stage. Therefore, the long term goal of the Glycomics Laboratory for the Development
of Ovarian Cancer Biomarkers is to apply the most advanced technologies toward the goal of identifying
glycoprotein and glycan markers that can detect ovarian cancer early. We are a multidisciplinary team with
expertise in cancer biology, glycomics, glycan array analysis, and translational glycoimmunology from
investigators at the University of Arkansas for Medical Sciences (UAMS), the Complex Carbohydrate
Research Center (CCRC) at the University of Georgia, and the Harvard Medical School Center for
Glycoscience at Harvard University. The investigators at UAMS specialize in biomarker discovery using
glycomic methods and functional studies of glycosyltransferase enzymes in ovarian cancer progression, the
co-investigators at the CCRC specialize in the mass spectrometry identification of O-linked glycans present on
the Notch receptor and the functional analysis of these glycans in Notch activation, and the co-investigators at
Harvard specialize in the development of antibodies binding to tumor-specific glycans and the development of
glycopeptide arrays. The aims of this application are (1) To develop and validate N-linked and O-linked
glycoforms for the detection of ovarian cancer and (2) To discover and develop glycosylphosphatidylinositol
(GPI) anchored protein glycoforms and GPI anchor binding proteins for the detection of ovarian cancer.

Public health relevance
NARRATIVE The research proposed is focused on the discovery and detection of tumor-specific glycans (sugars) linked to proteins in ovarian cancer. The detection of these glycans on multiple proteins will lead to sensitive assays for the detection and monitoring of ovarian cancer from patient blood. Therefore, the development and validation of these assays may improve the quality of life and survival of ovarian cancer patients in the future.